New York Consortium for Interdisciplinary Training in Kidney, Urological and Hematological Research (NYC Train KUHR)

Abstract
Traditional training in kidney, urologic or hematologic (KUH) research equips the basic, translational
and clinical investigator with specific knowledge and technical skills that are particular to each of these
individual disciplines. During their careers, however, investigators can find it challenging to cross boundaries
between their specific areas of expertise to address important questions in overlapping KUH disciplines. These
“leaps” have to be encouraged and taught, as it is through these interdisciplinary interactions and
collaborations that we will advance KUH research and achieve the scientific discoveries needed to improve the
care and quality of life of people with KUH diseases.
The training program that we propose in this U2C/TL1 application aims to prepare the next generation
of KUH investigators with the interdisciplinary knowledge, skills and mindset that will allow them to naturally
engage and seek interdisciplinary collaborations. To achieve this goal, we will harness the experience and
excellence in research and training of four of the leading medical schools in the New York City (NYC)
metropolitan region, the Albert Einstein College of Medicine, Columbia University Irving Medical Center, the
Icahn School of Medicine at Mount Sinai and the Renaissance School of Medicine at Stony Brook University,
to establish the “New York Consortium for Interdisciplinary Training in Kidney, Urological and Hematological
Research” (NYC Train KUHR)” (pronounced “NYC Train cure”). The Training Core will be developed around
the strong supporting system provided by the other NYC Train KUHR Cores: the Networking Core, the
Professional Development Core and the Administrative Core.
The Training Core will promote interdisciplinary thinking and support development of technical skills to
facilitate engagement in collaborations and team science. The proposed program builds on our experience
from three existing, successful nephrology T32 grants, an R25 grant, a T35 grant and an NIH O’Brien Center in
Urology. It also builds on the combined research and training strengths of over 100 preceptors from across the
four institutions that bring to the program their expertise in KUH research and complementary areas, including
genomics, developmental biology, epidemiology, neuroscience, bioengineering and clinical trials across the
lifespan. At its full capacity, the program will train 9 pre-doctoral and 16 post-doctoral fellows across the four
institutions. The training program will use independent development plans and thesis and scholarship oversight
committees to individualize trainee experiences. Emphasis will be placed on experiential mentored research
experiences as well as professional development activities to prepare the trainees for a research career in
academic medicine. The knowledge and skills learned from this training program and the other educational and
professional development activities promoted by the NYC Train KUHR will allow this new cadre of investigators
to work across different disciplines to develop novel concepts to advance KUH research.